Plasma cell differentiation of autoreactive B cells is governed by TLR9 dependent metabolic reprogramming

ABSTRACT SLE is a devastating systemic autoimmune disease of unknown etiology that presents with a diverse array of clinical symptoms and afflicts over 1.5 million Americans. Numerous risk factors have been identified, and it is generally accepted that SLE can result from a spectrum of immunoregulatory defects. However, one of the key events is a breach in tolerance of autoreactive B cells and their development into autoantibody producing plasma cells. Nucleic acid binding Toll-­like receptors (TLRs) have been found to play a critical role in the production of autoantibodies and disease development in all animal models of SLE that have been examined to date. Intriguingly, in these same models, TLR9 appears to play both a protective and disease promoting role;? TLR9 is required for the production of anti-­dsDNA autoantibodies, but surprisingly, TLR9KO autoimmune-­prone mice develop much more severe clinical disease than their TLR9-­sufficient counterparts. Previously, we have reported that activation of autoreactive B cells with TLR9 dependent DNA-­containing immune complexes causes rapid proliferation followed by cell death while activation with TLR7 dependent RNA-­containing immune complexes leads to plasma cell differentiation. The exact basis for this bifurcation in B cell differentiation is still under investigation. We have preliminary evidence that TLR9 uniquely regulates the NF-­k?B pathway by promoting Ik?Ba? degradation and expression of Ik?Bz?. Ik?Bz? is an important transcription factor that regulates the levels of pro-­inflammatory (IL6, IL12) and anti-­inflammatory cytokines (IL10). Recently, the expression of Ik?Bz? has been linked to the immunometabolite itaconate. Interestingly, TLR9KO B cells show a decreased oxygen consumption rate compared to WT B cells after immune complex activation suggesting a role for TLR9 in the regulation of metabolism. Putting these findings together, we hypothesis that TLR9 plays a key role in metabolic reprogramming of autoreactive B cells and subsequent modulation of important signaling pathways. In Aim 1, we will explore the role of TLR9 in increasing cellular metabolism in immune complex activated B cells and its inhibitory effect on plasma cell differentiation. In Aim 2, we will explore the pathways by which TLR9 dependent metabolic reprogramming modulates the NF-­k?B pathway downstream of B cell receptor crosslinking. Based on our hypothesis, we expect to identify key roles for itaconate and Ik?Bz? in plasma cell differentiation. Overall, the studies outlined in this application should provide important insights regarding the metabolic requirements of autoreactive B cells and its influence on B cell fate decisions. The findings from these studies may lead to the discovery of new therapeutic targets for SLE.

Public health relevance
PROPOSAL NARRATIVE Systemic Lupus Erythematosus (SLE) is a common and devastating autoimmune disease, characterized by dysregulated activation of autoreactive B cells by intracellular antigens like RNA and DNA, which activate Toll- like receptors (TLR) 7 and TLR9. Despite their identical signaling cascades in macrophages, TLR9 signaling in B cells seems to inhibit plasma cell differentiation while TLR7 promotes it, suggesting a bifurcation of signaling cascades downstream of TLR7 and TLR9, which may explain part of the observed protective role of TLR9 in SLE. In this proposal, we are exploring how TLR9 modulates NF- kB signaling by metabolic reprogramming and its effect on plasma cell differentiation – insights that may lead to the discovery of new targets for much needed therapeutics in SLE.